The Role of Biological Sex in the Self-renewal of B1 Cells into Old Age in Mice and Humans

Project Summary/Abstract
By the year 2050 the WHO predicts there will be 2 billion people aged 60 years and over. As the population of
aged individuals rises so will aging-associated diseases. To create better prevention strategies for diseases in
the elderly, we need to address fundamental biological questions regarding immune system deterioration
during the aging process. Specifically, the goal of this proposal is to determine whether defects in natural
immunity in the aged are due to changes in self-renewal of a subset of B cells, B1 cells, which produce natural
antibodies (NAbs).
NAbs are generated in the absence B1 cell stimulation and constitute a key modality of serological immunity
providing many essential functions within in immune system. The effectiveness of NAbs is attributed to their
distinct germline-like properties that result from development of B1 cells during fetal life with persistence into
adulthood. Our studies demonstrate NAbs are less effective at providing protection in aged males yet,
protection is maintained in aged females. If effective NAbs are maintained over a lifetime, these essential
proteins could aid in producing an increase in both health-span and lifespan; yet it is unknown how protective
NAbs are maintained in aged females but not aged males.
This loss in NAb protection against infection in aged males is not accounted for by a change in the amount of
antigen specific antibody, but instead, is due to the loss of antibody germline-like features, which does not
occur in aged females, where B1 cell derived antibody remains germline-like. Our preliminary and published
results suggest these findings are a result of better persistence of B1 cells that originate in fetal life with
advancing age in females as opposed to males. The reason for this is unknown but it is speculated that B1 cell
self-renewal is responsible. We hypothesize age and sex-associated defects in the protective capacity of
natural IgM results from loss of adult B1 cell self-renewal in aged males but not aged females. To test this
hypothesis, we will utilize advanced genetic techniques that provide the means for the first time to separately
track B1 cells originating in fetal life from those arising in adult life, and for the first time to measure the stage at
which B1 cells are in cell cycle, according to sex and age. We will 1) determine how biological sex influences
long term persistence of mouse B1 cells generated during different phases of life; 2) examine sex specific
regulation of mouse B1 cell cycle progression and self-renewal with increasing age; and 3) evaluate the role of
sex in specifying human B1 cell cycle dynamics and human B1 cell natural antibody function. This project will
elucidate mechanisms of differential B1 cell self-renewal in aged males and females, which will provide critical
information for designing novel approaches to maintain healthy natural immunity into old age by favoring self -
renewal of early appearing B1 cells.

Public health relevance
Project Narrative As the population of aged individuals rises so will the burden of aging -associated diseases that are counteracted by natural antibodies produced by a unique population of B lymphocytes termed B1 cells. B1 cells and the natural antibody protection they afford deteriorate with advancing age in males, but remain highly effective in females, although the reasons for this sex-associated disparity remain unclear. The present study is designed to fill this gap in knowledge by utilizing advanced genetic tools, biomolecular assays, and discrete antibody analysis to determine the mechanisms responsible for persistence of B1 cell number and function in older females so that it will be feasible to enhance B1 cell activity into old age for all.